Developmental Research Program

ABSTRACT: DEVELOPMENTAL AND RESEARCH PROGRAM CORE
The Developmental Research Program (DRP) of the Liver Cancer in American Indians/Alaska Natives (AI/AN)
Disparities (Li-CAD) P20 Program will support early-phase projects that have the potential to open new areas of
translational liver cancer research and ultimately, contribute to reducing morbidity and mortality and improving
quality-of-life for patients with hepatocellular carcinoma (HCC). Projects funded under the DRP are intended to
rapidly advance a new idea or concept that has the potential to substantially impact our understanding of liver
cancer to eliminate disparities and improve surveillance, early detection, and treatment of HCC in AI/AN persons
and thereby reduce or eliminate HCC-related mortality. The infrastructure of the DRP will establish mechanisms
to quickly respond to translational research opportunities within the Li-CAD P20 Program institutions that require
support to advance hypotheses or confirm feasibility in order to justify larger resource investments.
Developmental projects will include research in basic science, clinical science, and population-based studies,
and will build collaborations between Li-CAD sites and other institutions with P20 Programs and SPOREs in liver
cancer and disparities research.
Developmental projects may encompass a wide range of liver cancer research and treatment areas, including
basic science, etiology and prevention (primary and secondary), early detection, prognosis, therapeutics, and
survivorship. Collectively, the DRP is structured to strengthen collaborations between Li-CAD sites and initiate
interactions with other institutions with P20 Programs and SPOREs in liver cancer. DRP proposals will be
supported based on their potential to mature an original idea or concept into a translational research project that
will successfully attain independent funding, either within a subsequent P50 or from other government or
foundation sources. In addition, the DRP is designed to attract senior investigators with diverse scientific
expertise and junior investigators new to translational liver cancer research.
The Specific Aims for the Developmental Research Program are to:
1. Stimulate the development of innovative, impactful, early-phase research studies that include
multidisciplinary interactions with basic, clinical, and population scientists across the Li-CAD institutions;
2. Provide funding (1-2 years) and infrastructure (e.g., biospecimens, biostatistical support) to rapidly test
the feasibility of original investigator-initiated projects in all areas of HCC research;
3. Prioritize funding to rapidly exploit new opportunities or support specific areas of strategic importance for
advancing the translational research goals of the Li-CAD P20 Program; and
4. Monitor (and facilitate) the progress of each DRP project and consider their advancement to a full P50
SPORE project.

Public health relevance
While deaths related to lung, breast, prostate and colorectal cancer have declined dramatically by 40-53% between 1990 and 2016, hepatocellular carcinoma (HCC) is the only major malignancy whose mortality is rising in both men and women and has had the highest average annual percentage change. American Indian/Alaska Native (AI/AN) people face a disproportionally high burden of HCC with 2.4 times higher HCC incidence and 2.5 times higher HCC-related mortality than white persons. Our aim is to apply novel, innovative, translational approaches to surveillance and early detection of HCC that are informed by unique aspects of HCC pathophysiology and epidemiology in AI/AN people in order to eliminate disparities, improve early detection and ultimately reduce HCC-related mortality.